The Institute for Translational Medicine

Contact PD/PI: Solway, Julian
Chapter O: Overall
ABSTRACT
ITM 3.0: ADVANCING HEALTH TOWARD HEALTH EQUITY THROUGHOUT METROPOLITAN CHICAGO
The University of Chicago – Rush University Institute for Translational Medicine (ITM) was created in 2007 to
assemble, integrate, and create the intellectual, administrative, and physical resources required to catalyze
research and research training in Clinical and Translational Science. We have trained university scientists and
health care providers as well as stakeholders from concerned communities to work together to determine the
biological, behavioral, and social determinants of disease; to develop and test interventions directed toward
those mechanisms; and to achieve these goals in a way that is rigorous, efficient, ethical, respectful of, and
responsive to our communities’ priorities and values. The ITM has capitalized on outstanding intellectual and
physical resources throughout UChicago, Rush, and ITM affiliate institutions – Loyola University Chicago,
NorthShore University HealthSystem, Advocate Aurora Health Care, and Illinois Institute of Technology – and
on substantial multi-institutional investments to build the sustainable infrastructure for a transformative,
energetic, and self-improving home for clinical and translational research.
Now, we pursue a bold guiding vision for “ITM 3.0” – that reversing the adverse health consequences of
structural racism requires accounting for and mitigating the social, environmental, behavioral, and
psychological factors (the entire lived experience, which we will call the “sociome”) through which
structural racism impairs health. Focus on the sociome is critical because: 1) sociome factors interact with
human biology to exacerbate or cause disease and injury, and 2) illness of any origin can compound the
negative effects of adverse sociome factors. Since both sociome and biological systems, and their
interactions, determine health, our CTSA hub must provide investigators, trainees, and stakeholders with the
resources and knowledge to account for and address health disruptors throughout both systems. Our
strategy to implement this vision is to create new training mechanisms, research platforms,
communications channels, and safeguards against harm to ensure that all ITM investigators and
institutions approach health problems with a wider-angle sociome lens in an ethical way. Then, our
scientific, institutional, and community stakeholders can together design, test, and disseminate biological
and/or sociome-directed interventions at the levels of individual, community, and society to improve
mutually defined health concerns. ITM 3.0 will work hand-in-hand with partners throughout Chicagoland and
the nation, combining academic rigor with community wisdom to conceptualize, develop and deploy
innovative, just, and ethical interventions/practices to achieve our common goal, and so lessen the health
impact of structural racism.
Project Summary/Abstract Page 244
Contact PD/PI: Solway, Julian

Public health relevance
PROJECT NARRATIVE By promoting multidisciplinary team science, fully engaging institutional and community stakeholders in the design and implementation of health research, accounting for adverse aspects of the “sociome” – that is, the social, environmental, behavioral, and psychological factors through which structural racism impairs health – and developing innovative and sometimes disruptive approaches to advance the science and practice of clinical and translational research, we expect to mitigate disease risk, morbidity and mortality, improve the conduct and pace of health research, and ultimately improve the health – and health equity – of Chicago and the nation.